Multimodal Microscope for Live Cell Molecular Dynamics

Project Summary
This proposal seeks to replace Colorado State University’s first open-access spinning disk confocal (SDC)
microscope, installed in 2006, with a 3i Marianas super-resolution SDC, enhancing our research capabilities to
meet the demands of modern biological imaging. Whereas a laser scanning microscope uses a single pinhole
with the full intensity of the laser beam rastering across the object being imaged, an SDC spreads the laser beam
over a rapidly spinning disk containing hundreds of pinholes and microlenses, returning the fluorescence
emission through the same lenses, and building a full image much faster, often with less phototoxicity. Three
major upgrades, internally funded by shared costs between users and a centrally funded core, have allowed our
original SDC to function for 18 years, but its limitations for state-of-the art biological imaging in diverse model
systems have become all too apparent. Our research utilizes a broad range of biological models such as yeast,
mammalian cell culture, organoids, tissue slices, and model organisms including C. elegans and zebrafish. We
require the ability to rapidly detect faint single-molecule fluorescence signals for studying dynamic processes
such as transcription and translation, and many applications require broader fields of view, such as during
oogenesis or following multiple cells in a field. The 3i Marianas microscope will meet these diverse and modern
needs, providing our researchers with an easy-to-use super-resolution microscope that also provides a 3-fold
improvement in imaging brightness, allowing for both improved imaging quality and reduced phototoxicity. The
unique ability of the 3i Marianas microscope with the Vector3 TIRF module to rapidly switch between confocal
and TIRF/HILO imaging modes will also give our researchers the ability to track single molecules while
simultaneously co-imaging nearby structures with confocality, providing important biological context for acquired
tracks, even in thick samples such as C. elegans or mammalian sperm. Finally, the ability to combine these
imaging modalities with a photo-activation/conversion/photobleaching point scanner will enable the systematic
measurement of subcellular protein dynamics, for example, the timing of receptor-ligand binding or the
association of prion-like domains. Acquiring this microscope will significantly enhance our live-cell imaging
capabilities, enabling unprecedented insights into cellular processes and expanding what is currently possible at
our institution.

Public health relevance
Project Narrative: The instrumentation being requested will broadly impact the scientific research of 9 major users at Colorado State University who are currently funded from 5 different institutes of NIH, each of which relates to issues of public health. These include but are not limited to studies on basic mechanisms regulating gene expression and protein translation (important in understanding cancer), fertilization (mechanisms of sperm motility, oocyte development), brain synaptic development and irregularities occurring in autism, blood platelet development which impacts clotting, viral translation and processing in live cells, and furthering an understanding of prion proteins and their aggregation in age-related neurodegenerative diseases. Furthermore, the microscope will be housed in a core facility that has successfully operated for 18 years, providing essential imaging services to laboratories in biomedical sciences, engineering, and human nutrition, all prominent programs within Colorado State University.